Engineering Tools for Rapid Loss of Protein Function with Spatio-Temporal Control in Zebrafish

PROJECT SUMMARY
In zebrafish, the genetic toolkit is limited to global and tissue-specific gene inactivation. However, often it is
desirable to inactivate genes in specific tissues and at specific times. Moreover, phenotypes do not become
evident until pre-existing protein product from the targeted gene has decayed. This lag can be many hours or
even days. This is a problem when studying rapid biological processes or genes that are required for cell
survival. In recent years, several strategies have been developed to overcome these limitations. Most of the
strategies target the protein gene product directly, typically by tagging the protein with a degron that can be
induced to degrade the tagged protein. We recently adapted the deGradFP system from flies to zebrafish and
called it zGrad. zGrad targets GFP-tagged proteins for degradation and reveals loss-of-function phenotypes.
zGrad consists of a fusion of an anti-GFP nanobody to a F-box domain. zGrad binds GFP-tagged proteins
through its anti-GFP nanobody part and targets the tagged protein to the E3 ubiquitin ligase complex for
degradation through its F-box domain. In its current form, zGrad can be used to degrade proteins with either
spatial or temporal control, but not both. Here we propose to engineer significant improvements to the zGrad
system. Specifically, we will (1) expand zGrad so that it can be used to degrade proteins with combined spatial
and temporal control, and (2) engineer zGrad so that it is regulated through light to induce degradation in
specific cells and subcellular compartments at desired times. These improvements will make zGrad an
extremely powerful and versatile system for inactivating genes rapidly in specific cells at specific times in
zebrafish, and would provide proof-of-principle that the deGradFP/zGrad method could be adapted to function
in any system.

Public health relevance
PROJECT NARRATIVE Methods to inactivate specific genes in zebrafish are essential for uncovering basic insights into life, which translates into a better understanding of human development and disease. Existing methods for inactivating genes in zebrafish have limitations, including slow inactivation kinetics and the lack of combined spatial and temporal control. To overcome these problems, we propose to develop a set of protein depletion tools for zebrafish that will allow rapid protein inactivation with combined spatial and temporal control.